Center for Genomic Regulation

Abstract – Overview
Proper regulation of genomic structure and function is central to life and health. Dysfunction of cell division,
chromatin structure, and gene expression are common features and causes of human disease. As such,
understanding genomic regulation is central to elucidating disease processes and developing new interventions.
Technological and analytical advances are rapidly changing the research landscape in genomics, epigenomics,
and transcriptomics. While a core of genomics-related research has developed at the Oklahoma Medical
Research Foundation (OMRF), additional investigators and research resources are needed to bring genomic
regulation research at OMRF, and in Oklahoma more broadly, to the point of being a self-sustaining community
that is competitive in the field. While efforts are currently scattered across institutions and disease-focused
research efforts, the Center for Genomic Regulation (CGR) will be a nexus for the state of Oklahoma. The
goal of the CGR is to build a focused research community that performs collaborative research and effective
training. We define genomic regulation as studies examining chromatin, DNA modifications, genome structure,
and transcription. The CGR will support four accomplished Early Stage Investigator (ESI) Assistant Professor-
level faculty at OMRF as Research Project Leaders (RPLs). These RPLs have stellar training records and high
potential for successful and independent genomic regulation-related research careers. With the strategic
emphasis on genomics at OMRF and genomic regulation research represented across research programs at
OMRF, a steady pool of future RPLs is assured. The CGR will provide mentorship and research resources for
these early career investigators and support the development of their independent careers to R01 or R01-
equivalent funding. The CGR will be a hub for advanced research across organ and disease domains, integrating
genomic analysis technologies and data science capabilities. These goals will be accomplished through the
following Specific Aims: Aim 1: Support promising Research Project Leaders to scientific independence. Aim 2.
Promote novel genomic regulation research through mentoring the Research Project Leaders. Aim 3: Integrate
existing and new resources through the Epigenomics and Artificial Intelligence Cores to support genomic
regulation research. Aim 4: Promote an environment that supports the success and development of an
independent and sustainable center in genomic regulation.

Public health relevance
Narrative – Overview The scientific theme of the Center for Genomic Regulation is designed to address central questions of the current post-genomic era where genome sequences are known but how genetic information is stored, accessed, and utilized in health and disease remains to be understood. The Center will be a hub for advanced research across organ and disease domains, integrating genomic analysis technologies and data science capabilities. The goal of the Center is to build a focused research community that performs collaborative research and effective training in Oklahoma.